Transfusion Biology and Cellular Therapies

PROJECT SUMMARY
For the past century, a major focus for Transfusion Medicine has been the immune compatibility of blood
components with added attention to the safe and appropriate use of blood products. The success of these
investigations has fueled expansive growth in the field with efforts focused on developing novel blood
components for transfusion and to generate cellular therapies. These activities require a concerted effort to link
advances in basic science with therapeutic interventions in the clinic. Transfusion Medicine Scientists and
Specialists lead the effort to train individuals to advance blood and hematopoietic cellular therapies. The
overall goal of the Program in Transfusion Biology and Cellular Therapies continues to be the preparation of
M.D., M.D./Ph.D. or Ph.D. postdoctoral fellows for biomedical research careers. This long-standing program
entering its third decade has supported 80 postdoctoral fellows with over 40% of trainees being women or
underrepresented individuals. The T32 supports 8 postdoctoral fellows for 2-3 years enabling them to move on
to leading positions in academia or industry. As the field of Transfusion Medicine continues to grow, as does
the program to include the scientific areas around Immunobiology, Hematopoiesis, and Cellular Therapy. Major
strengths of our multi-disciplinary program include utilizing the strong clinical and basic research environments
at Harvard Medical School involving Boston Children's Hospital, Dana-Farber Cancer Institute, Brigham &
Women's Hospital, and Massachusetts General Hospital. In addition to scientific investigation, we have
developed programs to a) educate trainees in responsible conduct of research, grant writing, laboratory
management, and ensuring rigor and reproducibility of data b) offer opportunities to develop skills in public
speaking c) recruit and retain trainees from underrepresented or disadvantaged groups and d) maintain
academic oversight for scholarship to advance career development. Dr. John Manis will continue his role as
overall PI and has expanded the number of Program co-Directors to effectively represent both basic science
and clinical Transfusion Medicine. These leaders will be responsible for the scientific direction of the training
program, the mentoring of trainees as well as junior faculty, and monitoring milestones to ensure continued
success. We have assembled our faculty roster this year to increase contemporary scientific representation
from disciplines related to Transfusion and to better reflect the needs of our applicant pool. We believe our
approach of including broad representation of clinical, basic and translational research talent is a fundamental
strength of our program and fits well with the evolving field of Transfusion Biology and Cellular Therapies. This
distinctive training approach has generated a unique environment for trainees in the Harvard Medical Area and
ours remains a highly sought-after program. The outstanding pool of applicants and recruitment of faculty
dedicated to the program has facilitated this goal. Our evolving Training Program strives to provide a unique
and rich training environment for academic transfusion biology and cellular therapies.

Public health relevance
PROJECT NARRATIVE While an important focus of Transfusion Medicine has been to maintain immune compatibility of blood components as well as the safe and appropriate use of blood products, the expansive growth in knowledge of blood cell biology has correspondingly increased options for investigation. Transfusion Medicine scientists and specialists now direct the generation of novel blood component products and the translation of cell-based therapies. Our postdoctoral training program is tailored to meet the recognized need for scientific training of individuals to further advance knowledge and clinical use of hematopoietic cellular therapies to treat diseases.